Prostate Cancer Program

Prostate Cancer Program: Summary
The mission of the Prostate Cancer (PR) Program is to reduce the morbidity and mortality associated with
Prostate Cancer by leveraging a deep understanding of the disease at a biologic, clinical, and population level.
The Program approaches this mission with transdisciplinary research that is richly collaborative and
translational. Since the last competitive renewal, a strategic planning process led to the development of three
new transdisciplinary themes:
Theme 1: Discovery of Biologic and Molecular Drivers of Prostate Cancer
Theme 2: Biomarker and Prognostic Model Development to Predict Outcomes in Men with Prostate Cancer
Theme 3: Developing Therapeutic Interventions to Improve Outcomes for Men with Prostate Cancer
PR Program: Key Metrics
Membership (10 departments, 1 school) 37
Full 24
Associate 13
Cancer-relevant Funding (direct costs as of
$13,878,515
05/31/2017)
NCI $5,543,247 40%
Peer-reviewed $5,289,510 38%
Non-peer-reviewed $3,045,758 22%
Cancer-relevant Publications (1/2012-7/2017) 616
Inter-programmatic 160 26%
Intra-Programmatic 257 42%
High-Impact 198 32%
Accruals to Clinical Trials (2016) 923 46
Therapeutic 99 20
Other Interventional 416 12
Non-interventional 408 14